Molecular mechanism of PIN1-mediated regulation of the nuclear receptor PPARy

Project Summary/Abstract
Peroxisome proliferator-activated receptor gamma (PPARγ) is a ligand sensitive nuclear receptor and
master regulator of adipogenesis. There exist FDA approved drugs that bind the ligand binding domain (LBD) of
PPARγ to induce a well characterized conformational change, which alters the activity of this transcription factor.
However, the functionally critical N-terminal intrinsically disordered AF1 domain remains poorly understood from
a structural standpoint due to the limited number of biophysical methods that can provide atomic level detail of
binding interactions and AF1 conformational states. Peptidyl-prolyl cis/trans isomerase NIMA-interacting 1
(PIN1) is a known protein binding partner of PPARγ that exerts its catalytic activity specifically at pSer/pThr-Pro
motifs, facilitating the cis/trans isomerization of proline bonds along the peptide backbone. Preliminary data from
our lab and others suggest PIN1 binds the AF1 region of PPARγ with a much greater affinity than the LBD, an
observation which presents the opportunity to better understand the role of AF1 function in PPARγ biology. This
binding interaction suggests a cascade of post translational modifications (PTMs), including kinase-mediated
phosphorylation and PIN1 enzyme-catalyzed proline cist/trans isomerization of the AF1 region, may be
responsible for tuning the transcriptional activity of PPARγ and maintaining activation of adipogenic gene
programs. In this project I will use nuclear magnetic resonance (NMR) spectroscopy to monitor PTM
(phosphorylation and isomerization) induced changes in AF1 conformational states and correlate this data with
cellular function associated with PPARγ-mediated gene programs that influence adipogenesis and insulin
sensitization. Aim 1 of this project outlines the use of NMR methods to monitor and describe the phosphorylation-
dependent and isomerization-dependent conformational changes the AF1 domain undergoes. These NMR
studies will be complemented by kinetic and structural insight gleaned from biolayer interferometry (BLI)
experiments to measure binding affinity of AF1 peptides to PIN1, X-ray crystallography studies of PIN1 in
complex with AF1 peptides, and cross-linking mass spectrometry (XL-MS) using full length PPARγ and PIN1 to
identify intermolecular protein contacts which may not be exclusive to the AF1 domain. To correlate the structural
and molecular mechanisms described by Aim 1 with functional effects observed in cells, Aim 2 of this project
uses structure-guided mutagenesis, transcriptional reporter assays, and knockdown experiments in pre-
adipocytes to understand the role of PIN1 as a mediator of PPARγ function during adipogenesis. Gene
expression analysis and assays that measure cellular endpoints associated with PPARγ function will further
assess the roles of these PTMs within the AF1 domain in promoting adipogenic function.

Public health relevance
Project Narrative- Peroxisome proliferator-activated receptor gamma (PPARγ) is a ligand sensitive nuclear receptor which functions as a master regulator of adipogenesis and has broad relevance in metabolic syndrome and type 2 diabetes. Transcriptionally activating PPARγ ligands that bind to a C-terminal structured ligand- binding domain promote insulin sensitization and have been used clinically for type 2 diabetes treatment; however, it remains poorly understood how the N-terminal intrinsically disordered AF1 region of PPARγ regulates nuclear receptor activity on a structural level. In this project I will use structural methods well suited for studying disordered proteins along with cellular studies to gain insight into how the AF1 region interacts with protein binding partners in a post translational modification-dependent fashion to tune PPARγ cellular functions.